Regulation of RNA polymerase II transcription in trypanosomatids

Project Summary
Trypanosoma brucei is a single cell protozoan parasite that causes human African Sleeping Sickness, that is
fatal if untreated. Related trypanosomatid pathogens, including numerous Leishmania species, cause even
more morbidity and mortality worldwide. The regulation of gene expression is essential for parasite
development and survival in their sequential host environments. Exactly how trypanosomatid gene expression
is regulated is currently not well understood, but the relative contribution of transcriptional control was thought
to be absent. We have demonstrated a role for a modified DNA base, called base J, and histone H3 variant
(H3.V) in the regulation of RNA polymerase II (Pol II) transcription termination in T. brucei and L. major. This
includes sites within polycistronic gene clusters leading to “premature” termination and silencing of genes
downstream. Our long-term goal is to dissect epigenetic mechanisms of gene expression in trypanosomatids.
The objective of this grant is to determine the mechanism of J/H3.V regulated Pol II transcription termination in
T. brucei. The central hypothesis is that base J/H3V regulates termination via regulating specific stages of a
“torpedo-PP1” termination mechanism. The torpedo component involves 5'-3' exonuclease (XRND), helicase
(Sen1) and an RNA binding protein (RBP33). Pol II pausing and stimulation of the torpedo mechanism in other
eukayotes involves dephosphorylation of the C-terminal domain of Pol II by PP1 protein phosphatase as part of
the multimeric PTW/PP1 complex composed of regulatory subunits PNUTS, Tox4, and Wdr82 and PP1. We
have identified a similar complex in kinetoplastids, called PJJW/PP1, that replaced Tox4 with a J-binding
protein (JBP3). These data led to the current model where base J (via JBP3) recruits the PJJW/PP1 complex
at termination sites and PP1 dephosphorylates Pol II CTD, pausing elongation allowing the torpedo
mechanism to efficiently dissociate Pol II. Our specific aims will test the following hypothesis: Aim 1 will directly
test our torpedo model by assessing the role of these protein factors in transcription termination in T. brucei.
We will then analyze the function of individual protein components using a combination of in vitro and in vivo
analyses. Aim 2 will characterize the PJJW/PP1 complex, including the roles of PNUTS and JBP3 as the
assembly and chromatin recruitment factor, respectively. Aim 3 will elucidate the role of the PJJW/PP1
complex in termination, including the function of PP1 in modifying the CTD of pol II. The proposed work will
provide a fundamental understanding trypanosomatid gene expression, yielding a comprehensive view of the
role of transcriptional control and clues to it mechanisms. These studies may prove useful in identifying novel
approaches to prevention, treatment and diagnosis of the debilitating and deadly diseases caused by these
parasites.
!
!
!
!

Public health relevance
Project Narrative Parasitic protozoa are a major cause of global infectious disease and therefore represent a serious threat to public health. One such protozoan, Trypanosoma brucei, is the causative agent of human sleeping sickness, a vector-borne disease causing 300,000 to 500,000 infections each year. The goal of this application is to determine the mechanism of RNA polymerase II transcription termination; a detailed understanding of which will lead us to new parasite specific interventions to treat and prevent disease. ! !